Integrating developmental neurotoxicity screening using automated neuro-behavioral, morphological and neuro-developmental tests in the larval zebrafish

Integrating developmental neurotoxicity screening using automated neuro-behavioral,
morphological and neuro-developmental tests in the larval zebrafish
Abstract: Zebrafish is a model that holds immense promise for screening effects of environmental
chemicals on nervous system development and has the potential to reveal pathways of developmental
neurotoxicity (DNT) in order to provide a sound basis for human-risk assessment. Experiments using the
zebrafish for DNT can be broadly categorized as gene expression profiling, neuroimaging and
neurobehavioral assessments. Gene expression profiling studies can be scaled in throughput but
neuroimaging and neurobehavioral experiments are assessed using imaging systems where throughput,
analysis automation and standardization are known bottlenecks. Currently, single-camera systems used
for neurobehavioral assessments can provide 2D behavior metrics but don’t have sufficient resolution to
screen for morphology. Similarly, for neuroimaging assessments, current single objective imagers
step-and-scan over every well to screen an entire well plate in several minutes, but can’t perform
longitudinal assays (for e.g. timelapse). Moreover, no imaging system currently exists to our knowledge
that can assess 3D behavior and lateral morphology of zebrafish at a sufficiently high throughput (> 40
fish at a time). Here we propose to use our novel Multi-Camera Array Microscope (MCAM) Technology
stack to develop an integrated high-throughput imaging system (MCAM-DNT), an innovative
“periscopic”multi-well assay plate and associated analysis software for integrated assessments of
neurobehavioral and neuroimaging experiments on the same system. For neuroimaging, our proposed
system will enable non-invasive monitoring and profiling of changes in regions of expression through
development across an entire well-plate within seconds. For neurobehavior assessments, we will obtain
lateral morphology as well as dorsal morphology, 2D behavior and 3D behavior in an automated fashion
for unmounted and freely swimming fish upto 48 at a time. Lastly, a user facing software will collate
actionable insights from neurobehavior and neuroimaging assessments to present to the user as well as
for downstream analysis. This phase-1 grant is the first step towards establishing the utility of the
MCAM-DNT imaging system and analysis software for DNT screening in model organisms (planaria,
medaka) beyond the zebrafish.

Public health relevance
Narrative: Zebrafish is an excellent model for screening Developmental Neurotoxicity (DNT). However, neuroimaging and neurobehavior assessments for DNT screening are imaging based, and are manual and limited in throughput with critical gaps in high-throughput morphological assessments. The proposed MCAM-DNT imaging system with its novel “periscopic” multi-well plate will be the first system to integrate 2D behavioral as well as 3D behavioral, lateral morphology, dorsal morphology and gross fluorescence imaging assessments for DNT screening. This will be a significant leap in DNT screening using zebrafish for throughput, automation and standardization of assessments on one integrated system.